Targeting vascular dysfunction to promote lung repair and fibrosis resolution

ABSTRACT
Idiopathic Pulmonary Fibrosis (IPF) is a chronic, fatal disease of aging with limited therapeutic options. Despite
IPF lungs feature vascular abnormalities, including capillary rarefaction and vascular leak, the impact of vascular
endothelial dysfunction in the progression of this disease has remained unexplored. This proposal is designed
to fill this knowledge gap. Multi-omics analysis of endothelial cells (ECs) from young and aged mouse lungs
performed in our laboratory implicated the transcription factor ERG as an orchestrator of pulmonary vascular
repair and inflammation, whose homeostatic function is impaired during fibrosis with aging. Genetic ablation of
endothelial ERG in young mice led to increased inflammation, vascular rarefaction, and perpetuated lung fibrosis
following bleomycin challenge mirroring the aged lung phenotype. ERG silencing in human lung ECs in vitro led
to the increased secretion of fibrogenic mediators that promoted IPF-derived lung fibroblast activation. Whole
lung scRNA-seq combined with FACS analysis revealed reduced number of lung progenitor ECs, known as
general capillary (gCap) ECs, in ERG deficient mice compared to WT mice; this alteration was also observed in
lungs derived from IPF patients. Pharmacologic inhibition of the enhancer-binding protein and epigenetic
regulator BRD4 reversed inflammatory responses in ERG-silenced human lung ECs in vitro and restored gCap
EC identity in IPF lung explants ex vivo. Moreover, IPF and bleomycin-induced mouse lung fibrosis were
associated with overexpression of genes that regulate necroptosis, a form of programmed inflammatory cell
death implicated in aging and fibrosis. In addition, inhibition of necroptosis with the specific inhibitor Necrostatin-
1
attenuated inflammation induced by ERG silencing in human lung ECs. Based on these findings we
hypothesize that aging-associated epigenetic remodeling impairs ERG transcription in injured lung gCap ECs
leading to dysregulated inflammation, capillary rarefaction, and persistent lung fibrosis.
Aim 1 of this proposal
will characterize the influence of ERG on lung gCap EC regeneration and fibrosis. Aim 2 will define the role of
epigenetic mechanisms in lung endothelial ERG chromatin interaction, transcription, and vascular aging. Aim 3
will establish the contribution of endothelial necroptosis to lung vascular abnormalities and fibrosis in aged mice
with compromised ERG functions. We will test our hypothesis using in vitro, ex vivo and in vivo models including
an organotypic model of human IPF. gCap-enriched ECs and fibroblasts will be isolated from human IPF lungs.
Endothelial fibrogenic activity will be evaluated in an endothelial-fibroblast co-culture systems. Conditional
knockout and lineage tracing approaches will be used to investigate the role of ERG in endothelial homeostasis
and lung fibrosis. Fibrosis, vascular leak, capillary rarefaction, and hypoxia will be evaluated with molecular,
biochemical, and histological methods. Additional methods include immunohistochemistry, ChIP-seq analysis,
and pharmacologic inhibition of selected targets. This proposal will define endothelial alterations that are critical
in the progression of lung fibrosis toward our long-term goal of identifying novel targets for the treatment of IPF.

Public health relevance
NARRATIVE Idiopathic Pulmonary Fibrosis (IPF) is a chronic, fatal disease of aging with currently limited therapeutic options. This proposal is designed to study the hypothesis that dysfunction of the pulmonary vasculature plays a critical role in the progression of lung fibrosis. Experiments of this grant will investigate the contribution of molecular abnormalities we have discovered in the lung vasculature toward our long term goal of identifying novel targets for the treatment of IPF.